HSV-1 preferentially induces neuroinflammation and senescence in female mice.

Project Summary
Human alphaherpesvirus 1 (HSV-1) continues to be an important human pathogen because it
infects two-thirds of the adults in the world. Following acute infection, HSV-1 establishes and
maintains life-long latency in neurons within trigeminal ganglia (TG), and other neurons within
the central nervous system, including brainstem. External stressful stimuli periodically induce
reactivation from latency, which triggers virus transmission. HSV-1 reactivation from latency is
essential for virus transmission and recurrent disease: including ocular disease, encephalitis,
and congenital infections. The principal sensory nucleus of the spinal trigeminal tract (Pr5) and
locus coeruleus (LC) regions of the brainstem receive afferent inputs (directly or indirectly) from
TG. Consequently, brainstem is a biologically relevant site for viral replication and reactivation
from latency. Our recent published study revealed wild-type (wt) HSV-1 and a latency
associated transcript (LAT) mutant, referred to as dLAT2903, preferentially induce expression of
neuroinflammatory and senescence markers in Pr5 of latently infected female, but not male
mice. Strikingly, dLAT2903, but not wild-type HSV-1, preferentially induces expression of
senescence and neuroinflammatory markers in LC of females, but not male mice. Pr5 contains
many motor neurons whereas LC primarily contains medium-sized neurons. LC is also
the principal site for norepinephrine synthesis in the brain. New studies suggest LAT
expression impairs neuroinflammation in latently infected TG neurons or productively infected
human astrocytes derived from brainstem. Based on these female dimorphic responses to
HSV-1 infection, we hypothesize that Pr5, LC, and TG of female mice are predisposed to
senescence, neuroinflammation, and potentially neurodegeneration during latency. To test our
hypothesis, two Specific Aims are proposed. Specific Aim 1 studies will identify cellular genes
that regulate neuroinflammation in TG, Pr5, and LC during latency and localize LAT coding
sequences that impair neuroinflammation. Specific Aim 2 studies will identify senescent cells in
brainstem and test whether LAT impairs senescence and inflammation in cultured human
brainstem astrocytes. Completing these studies will provide insight into the mechanism by
which HSV-1 causes neuroinflammation, including how LAT mediates this process.

Public health relevance
Project Narrative/Relevance Human alphaherpesvirus 1 (HSV-1) infection causes cold sores, genital lesions, encephalitis and serious ocular disease. Unfortunately, antiviral drugs are not always effective. Exciting new studies revealed HSV-1 latently infected female mice exhibit enhanced neuroinflammation and senescence in brainstems of latently infected female mice. The proposed research will identify cellular genes that mediate sex-specific neuroinflammation and senescence in brainstem of mice.